Genomic and Transcriptomic Analysis of Breast and Ovarian Cancers

ABSTRACT
Ovarian and breast cancers share common genetic and lifestyle/environmental factors. GWAS have identified
more than a hundred genomic regions containing common variants associated with risks of these cancers,
several of which confer risks to both cancers. The molecular features of the aggressive subtypes of these
cancers--high grade serous ovarian cancer (HGSOC) and estrogen receptor (ER) negative breast cancer—are
also remarkably similar, suggesting common genetic and biological mechanisms driving disease development.
In the current proposal, we aim to focus on pleiotropic mechanisms underlying susceptibility to ovarian and
breast cancer, through tissue-specific transcription-wide analysis of gene expression associated with common
variant risk alleles for ovarian and breast cancer identified by GWAS. We will apply a new gene-based
association method, PrediXcan, to test the molecular mechanisms through which genetic variation affects
ovarian and breast cancer development. The proposed integration of germline genetic data with annotation of
whole genome transcription in the relevant tissue types effectively reduces the multiple testing burden faced by
GWAS by grouping together multiple risk loci at the gene-level, and further simplifies additional
characterization of implicated pathways. We hypothesize that the biological relevance of predictors provided by
PrediXcan will allow us to overcome tumor heterogeneity and identify novel genes/pathways for ovarian and
breast cancer. We then propose performing functional analyses in experimental models of breast and ovarian
cancer to validate the genes and pathways we identify using PrediXcan.
This proposal incorporates novel methodology integrating multiple sources of genomic and transcriptomic data
to identify the role of genetically regulated gene expression traits in the pathogenesis of ovarian and breast
cancers. Mortality is highest for the specific subtypes of these cancers that we will focus on, since the
mechanisms underlying the pathogenesis of these cancer subtypes are poorly understood. Genotype and
phenotype data from the GAME-ON, OCAC and BCAC consortia, along with the publicly available datasets,
TCGA, METABRIC and GTEx, represent a unique opportunity to apply the PrediXcan approach in a large-
scale for a well-defined group of cases and controls with high quality epidemiologic data resources .

Public health relevance
PROJECT NARRATIVE Ovarian and breast cancers are responsible for nearly half a million deaths a year worldwide and have shared genetic and environmental etiologies. Identifying common pathways underlying susceptibility to ovarian and/or breast cancer through transcription-wide analysis of gene expression associated with risk variants will lead to a better understanding of the mechanisms underlying the pathogenesis of these cancers and their most aggressive subtypes. We propose to incorporate novel methodology integrating multiple sources of genomic and transcriptomic data to identify the role of genetically regulated gene expression traits in the pathogenesis of breast and ovarian cancers which will overcome limited samples sizes and disease heterogeneity, based on the hypothesis that multiple risk loci are driven by similar functional mechanisms. Data from these studies may also identify clinical biomarkers that represent screening targets for the diagnosis of early stage disease and prevention.